Unlocking Trafficking Specificity for Cx43 Gap Junctions

Disturbances in ion channel function is a fundamental aspect of the arrhythmias of sudden
cardiac death. Recently, there has been is increased appreciation that cardiac ion channels have very
short half lives, and much of disturbed ion channel function in disease results from altered trafficking
and altered localization to the appropriate subdomain. Regulation of intracellular trafficking remains
poorly understood for cardiac ion channels.
In previous studies, we have identified how Connexin43 (Cx43) gap junction hemichannels
undergo cytoskeleton based Targeted Delivery to cardiac intercalated discs. Recently, we found an
endogenous truncated isoform of Cx43, the alternatively translated GJA1-20k, which is essential to full
length Cx43 forward trafficking and can rescue ischemia induced defects in Cx43 gap junction
localization. Our studies reveal that GJA1-20k is a critical molecule for channel and organelle
movement. Understanding the molecular details of its role in cardiac muscle cells will reveal
fundamental mechanisms of channel localization and also facilitate translational use of this molecule
into novel and clinically important therapeutic strategies.
The objective of this application is to explore the molecular mechanisms by which GJA1-20k
organizes trafficking highways. Our central hypothesis is that GJA1-20k, which increases during
episodes of myocardial stress, is a powerful cytoskeleton actin nucleator that builds the dynamic
trafficking highways essential for Cx43 gap junction delivery.
Our expertise in ion channel trafficking and identification of GJA1-20k, as well as our cell
biological tools and the new mouse model we generated for this proposal, allow us to successfully carry
out the planned experiments by pursuing two specific aims: 1) Is GJA1-20k essential to the formation of
Cx43 gap junctions in vivo? 2) Is GJA1-20k an actin nucleator, capable of patterning cytoskeleton
pathways for channel delivery?
Once successfully completed, the expected outcomes are to identify that GJA1-20k is a vital
cardiomyocyte protein whose mechanism of action is inherently linked to the actin and microtubule
cytoskeleton, is important in baseline healthy heart, and essential during times of stress. Such results
are expected to have a positive impact because we will have introduced a new therapeutic approach
(exogenous GJA1-20k) to limit pathologic trafficking in arrhythmogenic disease. At the same time, and
perhaps of even more long-term consequence, the studies will help resolve a fundamental unsolved
mystery in the biology of protein trafficking which is how membrane proteins are delivered directly to
their respective subdomain.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to NIH because it is a proposal focused on fundamental biology that will impact cardiovascular science. By exploring a paradigm known as Targeted Delivery in the context of cardiac ion channels, the research will unlock fundamental basic mechanisms of channel delivery. The basic research also has translational implications for treating arrhythmogenic heart disease.